Identification of Clinically Important Microbes by Genomic and Proteomic Methods

Following a quantitative blood-based assay detecting M. tuberculosis-specific peptides in
digested serum samples, we have identified target peptides for the detection of important
nontuberculous mycobacterial species. In addition, a blood-based molecular assay
was developed for detection of M. avium complex (MAC) using CRISPR methodology.
We unveiled two mechanisms of resistance responsible for the progressive development of
extremely high-level imipenem resistance in M. abscessus: i) A partial deletion in the porin gene
cooccurred with a first fourfold increase in MIC. ii) An increase in transcription level and enzymatic
activity of M. abscessus β-lactamase accounted for the subsequent eightfold increase in MIC
leading to a high-resistance phenotype.
We developed a quantitative droplet digital PCR (ddPCR) scheme for rapid detection of
clarithromycin resistance discriminating between full-length or truncated (inactive) erm(41)
inducible resistance in M. abscessus and a probe based ddPCR screening assay for assessment
of 23S rRNA rrl mutational resistance in M. abscessus and MAC.